Administrative Core

Project Summary/Abstract
Since 2007, the Administrative Core has deftly identified and accomplished tasks related to the
operation and success of this P01 through two granting cycles. This experience will be
leveraged in the next granting cycle to permit the P01 leadership to again use the Administrative
Core as the primary means to assure continuous integration and interaction among all P01
components and to oversee the research projects and other cores. This Core facilitates rapid
communication and connection among investigators, projects, and cores through face-to-face
meetings, written reports, and electronic communication. This Core assists sharing our research
data with investigators both within and outside of Memorial Sloan Kettering (MSK) with a special
emphasis to link Dr. Lovly and her Project 3 team at Vanderbilt with all facets of the program
project through electronic communication and videoconferencing. The Administrative Core
provides (1) administrative services; regulatory and reporting services, including preparation of
annual reports and renewals; (2) budget management; (3) publication management and
oversight; (4) videoconferencing for all P01 activities; (6) scheduling of P01 "work-in-progress"
conferences for the investigators and yearly face-to-face presentations to our advisory
committees; and (6) support of the oversight activities of the Executive and Advisory
committees. The Administrative Core centralizes, expands, and improves the operational
capabilities of the individual research projects and cores, avoids duplication, and ensures
optimum utilization of resources. The MSK Lung P01 Program Manager supported by this Core
meets at least 4 times a year with the Principal Investigators and the Executive Committee to
assist in monitoring operations so that the research supported by the program project proceeds
efficiently. The MSK Lung P01 Program Manager, with Drs Kris and Ladanyi, prepares and
distributes a yearly progress report for the Executive and the Scientific Advisory Committees to
assist in their review and oversight. The Administrative Core supports the Project and Core
Leaders, the Executive Committee, and the Advisory Committees. It provides services that are
essential for the P01 to function as an integrated research program to develop new targets for
treatment for persons with lung cancers.

Public health relevance
Project Narrative Lung cancers are America’s leading cancer killers, responsible for 158,000 deaths this year. This grant addresses two critical roadblocks to improving the care and curability of persons with these illnesses: understanding how cancers spread (metastasis) and the lack of medicines to prevent spread or to eradicate cancers that have spread from the lungs. The Administrative Core unites, integrates, and evaluates the components of this P01 is critical to this effort.